Validation of Patient-Specific, iPSC-based In Vitro Liver System

'(1 0$4(1$# //+(" 2(.- (1 (- 0$1/.-1$ 2. 2'$ $0(2 $4($5 (+.2 0.)$"2 5 0#1 2. +(# 2$
.4$+ -(, + .0 $++ ! 1$# .#$+1 .% (1$ 1$1 -# (1 "$-2$0$# .- 4 +(# 2(-& - ,("0.%+3(#(" ,.#$+
.% -.- +".'.+(" 12$ 2.'$/ 2(2(1 /$"(%(" ++7 2'$ /0./.1$# 123#7 (1 7$ 0 /(+.2 /0.)$"2 2' 2 %.++.51 2'$
&3(#$+(-$1 2. 4 +(# 2$ "$++ 2(113$ "3+230$ ,.#$+1 .% #(1$ 1$1 $ & .0& -1 .- "'(/ 2. 0$/+ "$ "300$-2+7 31$#
-(, + ,.#$+1 .% #(1$ 1$1 2' 2 0$ (,/.02 -2 2. 2'$ '$ +2'" 0$ .% $2$0 -1 - "".0# -"$ 5(2' 2'$ 2'$
/0./.1 + (1 2$"'-.+.&7 #0(4$- /0.)$"2 2' 2 (1 - 00.5+7 %."31$# .- 11$11(-& 2'$ %(#$+(27 .% 2'$ ,.#$+ .%
'3, - #(1$ 1$ ".,/ 0$# & (-12 25. $12 !+(1'$#9!32 +(,(2$#9 -(, + ,.#$+1 .- +".'.+(" % 227 +(4$0 #(1$ 1$
(-"+3#(-& 2'$ //0.6(, 2$+7 .% % 227 +(4$0 / 2($-21 5'. #$4$+./ (21 /0.&0$11(4$ %.0, 0$
120.-&+7 11."( 2$# 5(2' 2'$ ,$2 !.+(" 17-#0.,$ (-"+3#(-& .!$1(27 (-13+(- 0$1(12 -"$ -# #( !$2$1 #71+(/(#$,(
-# '7/$02$-1(.- 2' 2 0$ ++ /0$4 +$-2 5(2'(- 2'$ $2$0 - ".,,3-(27 '(+$ 2'$0$ 0$ "300$-2+7 -. $%%$"2(4$
,$#(" 2(.-1 2. 20$ 2 -. -.- (-4 1(4$ !(., 0*$01 2. $%%$"2(4$+7 #$2$0,(-$ #(1$ 1$ /0.&0$11(.- -# -.
$%%$"2(4$ /+ 2%.0,1 %.0 '(&' 2'0.3&'/32 .0 /$01.- +(8$# #03& 1"0$$-(-& 2'(1 4 +(# 2(.- 123#7 (1 -$"$11 07 !$%.0$
- /$01.- +(8$# 11 7 2' 2 0$/+ "$1 -(, + ,.#$+1 .0 (-4$12(& 2$1 ,$"' -(12(" " 31$1 .% #(1$ 1$ " -
!$ $,/+.7$# 2. ##0$11 /0.&0$11(4$ '$/ 2(" #71%3-"2(.- "(00'.1(1 -# +(4$0 % (+30$ #3$ 2.
'$ /0.)$"2 32(+(8$1 #$ (#$-2(%($# (1 %0., / 2($-21 5(2' -# 5(2'.32 2. 4 +(# 2$ 1712$, 2' 2
(-".0/.0 2$1 ,3+2( +(-$ &$ +(4$0 "$++ /./3+ 2(.- (- ,3+2( "' --$+$# ,("0.%+3(#(" #$4("$ 2' 2 0$1/.-#1 2. &32
11."( 2$# % 227 "(#1 -# +$ #1 2. %(!0.1(1 -# (-"0$ 1$# +(/(# ""3,3+ 2(.- (- 2'$ ( #$0(4$# +(4$0 .0& -.(#
2(113$ '$ #$&0$$ .% +(/(# ""3,3+ 2(.- ".00$+ 2$1 5(2' 2'$ #(1$ 1$ 12 2$ .% 2'$ #.-.0 5(2' (-"0$ 1$# +(/(#
""3,3+ 2(.- .!1$04$# (- ( #$0(4$# .0& -.(# 2(113$ %0., / 2($-21 5(2' ".,/ 0$# 2. 2'.1$ 5(2' -.0, +
+(4$0 %3-"2(.- '$ ,("0.%+3(#(" 1712$, (1 4 +(# 2$# & (-12 ".,,.-+7 31$# ,.31$ ,.#$+ .%
! 1$# 3/.- '(&' % 2 '(&' " +.0($ #($21 5(2' 13//+$,$-2 + %03"2.1$ .0 %03"2.1$ 13"0.1$ -# -.4$+ ,.31$ ,.#$+
.% 2' 2 32(+(8$1 '3, -(8$# +(4$0 ,.#$+ 4( %3, 07+ "$2. "$2 2$ '7#0.+ 1$ #$%("($-2 ' &
+ 0& ,("$
'$ 123#7 (1 (--.4 2(4$ 2'0.3&' (21 31$ .% / 2($-2 1/$"(%(" (1 #(%%$0$-2( 2$# (-2. ,3+2(/+$ +(4$0 13! 27/$1
'$/ 2."72$ 12$++ 2$ 3/%%$0 $2" 2. #$4$+./ - ,.#$+ .% 0$+ 2$# 0$ # .321 +(/(# ""3,3+ 2(.-
,$2 !.+.,("1 +(/(#.,("1 ,.+$"3+ 0 - +71(1 %(!0.1(1 2' 2 , 7 !$ (-%+3$-"$# !7 2'$ #(1$ 1$ 12 2$ .% 2'$ "$++3+ 0
1.30"$ '$ /0.)$"2 !0(-&1 2.&$2'$0 ".,/+$,$-2 07 2$ , .% $6/$021 5(2' $6/$0($-"$ (- !(.$-&(-$$0(-&
,("0.%+3(#("1 ( -# .0& -.(# "$++ !(.+.&7 +(/(# ,$2 !.+(1, -# '$/ 2.+.&7 2. 4 +(# 2$ -.4$+ ,.#$+
31(-& 12 -# 0# -# "322(-& $#&$ ,.31$ ,.#$+1 .%

Public health relevance
NARRATIVE The number of patients with non-alcoholic steatohepatitis (NASH) in the United States will continue to escalate due to the high prevalence of the two main risk factors for the disease—obesity and diabetes that are both higher within the Veteran community compared to the general public. From a public health standpoint, there are no effective medications to treat NASH, no biomarkers for disease progression, and no effective high- throughput screening technologies. The goal of the project is to benchmark the in vitro microfluidic system against two animal models of NASH. The technology has unique advantages afforded by its ability to be a high- throughput system that utilizes patient-specific cells that can be obtained with minimal intervention. Once validated here, the microfluidic system will enable improved diagnostics, uncover molecular pathways and identify new treatments for a disease that leads to liver cancer, need for transplantation, and oftentimes death.